Hypoxia Inducible Factors and Hypoglycemia in Early Diabetic Eye Disease

PROJECT SUMMARY:
Diabetes accounts for 10% of healthcare spending in the United States. A growing portion of this cost is
spent on treatments for diabetic eye disease, the leading cause of blindness among working-age adults in the
developed world. Early nonproliferative diabetic retinopathy (NPDR) is driven by hyperglycemia that promotes
injury to the retina microvasculature. On the other hand, proliferative diabetic retinopathy (PDR) develops after
progressive microvascular damage ultimately results in retinal ischemia and subsequent hypoxia, driving the
expression of factors that promote angiogenesis. Several labs have demonstrated that the regulation of
angiogenic genes in late stages of diabetic eye disease is mediated by the transcription factor, hypoxia-inducible
factor (HIF) in patients with retinal ischemia and PDR. However, a role for HIF in early stages of diabetic
retinopathy (DR) is unclear.
We recently demonstrated that transient episodes of hypoglycemia promotes the nuclear accumulation
of HIF-1α, independent of hypoxia. This, in turn, results in an increase in expression of the angiogenic mediators
that promote the growth of abnormal, leaky vessels in patients with DR. More recently, we have observed that
activation of the p38 signaling pathway is necessary for HIF-1α accumulation in response to transient
hypoglycemia. These observations implicate the p38/HIF-1 pathway in early. Events in the promotion of DR
progression, independent of retinal ischemia. Based on these observations, we propose that inhibiting the
p38/HIF-1α pathway will be an effective approach to prevent the progression of DR. In this proposal, we use a
combination of genetic and pharmacologic approaches to evaluate the safety and efficacy of therapies that target
HIF-1 (SA1) or p38 (SA2) to prevent the progression of DR.

Public health relevance
PROJECT NARRATIVE: Most patients with diabetic eye disease – one of the most common causes of severe vision loss in working-age Americans – respond inadequately to current therapies. Moreover, aside from tight control of serum glucose, little else can be offered to patients to help prevent the development of early stages – or progression to late stages – of diabetic rertinopahy, highlighting the need to examine new molecular targets for its treatment. To expose novel therapeutic targets for the early treatment and/or prevention of this vision-threatening disease, we propose to interrogate the molecular basis whereby hypoxia inducible factor (HIF) accumulation in response to glucose dysregulation promotes progression of early diabetic eye disease.